CANCER CENTER SUPPORT GRANT

ABSTRACT Karmanos Cancer Institute (KCI) is the largest cancer care and research network in the state of Michigan (MI). There are 16 KCI sites serving a catchment area covering 46 of Michigan’s 83 counties, home to 6.7 million residents and 95% of KCI patients. Both African Americans (AfAms) and rural residents are disadvantaged by striking cancer disparities in incidence and mortality as well as cancer risk factors. According to the MI Behavioral Risk Factory Surveillance Survey, the proportion of overweight adults is highest in the more rural regions of the KCI-CA and the proportion of obese adults is highest in the predominantly AfAm city of Detroit as well as in the more rural, central region of the state. Report of no leisure activity is also higher in Detroit compared to other areas. Additional data from the by Detroit Research on Cancer Survivors (ROCS) Study show that AfAm cancer survivors were significantly less likely to report engaging in regular physical activity post-diagnosis versus a comparable White sample and less than one-quarter of survivors reported patterns of physical activity consistent with meeting the American Cancer Society (ACS) guidelines of 150 minutes or more per week of moderate to vigorous physical activity. Partnership with the Michigan Cancer Consortium (MCC), the state’s comprehensive cancer coalition, holds strong potential to address these problems. The MCC was responsible for developing the Comprehensive Cancer Control Plan for Michigan, 2021 – 2030 and among the priorities for 2021-2023 is increasing the percent of Michigan adults over 18 who have ever been diagnosed with cancer who meet the guidelines for aerobic physical activity and for muscle- strengthening activity. In response to the needs described, the proposed work has two specific aims. First, we will partner with the MCC to create and coordinate a statewide workgroup to increase physical activity among adult cancer survivors. Second, we will implement evidence-based strategies to increase physical activity among adult cancer survivors in collaboration with the statewide workgroup. The PAS workgroup will develop a CME activity to educate oncology and other healthcare providers about physical activity guidelines for cancer survivors and will implement a data-driven high-intensity interval training (HIIT) program for cancer survivors at one urban and one rural site within the KCI catchment area. Through these activities, we will be able to leverage the MCC infrastructure to extend the impact of cancer center’s resources and science through the KCI catchment area.

Public health relevance
NARRATIVE The low proportion of cancer survivors who meet recommended guidelines for physical activity has been identified as an area in need of improvement by both Karmanos Cancer Institute (KCI) community outreach and engagement surveillance, cohort studies conducted by KCI population scientists, and the Michigan Cancer Consortium (MCC), the state’s comprehensive cancer control coalition. The proposed work will build a new partnership between KCI and the MCC through creation and coordination of a Physical Activity in Survivorship (PAS) workgroup tasked with increasing the percent of Michigan adults over 18 who have ever been diagnosed with cancer who meet recommendations for aerobic physical activity and muscle- strengthening activity, an MCC priority for 2021-2023. The PAS workgroup will implement and evaluate both provider-focused and survivor-focused interventions, including an evidence-based high-intensity interval training (HIIT) program, as part of statewide efforts to address this priority.